Center on the Economics and Demography of Aging

The UC Berkeley Center on the Economics and Demography of Aging (CEDA) provides an outstanding infrastructure to develop and pursue research that shapes scholarly understanding of the social science determinants of population-level older adult health, and research that informs public policy on aging. CEDA has earned an international reputation as one of the leading research centers in the world for the economics and demography of aging, drawing on the Berkeley Department of Demography as a leading research and training program in these fields. CEDA’s mission is to promote and disseminate path-breaking theoretical, methodological, and empirical research focused on four signature themes: (1) Mortality measurement, (2) Policy and behavioral determinants of adult health, (3) Biodemography of aging, and (4) Macro consequences of global aging. Cross-cutting these themes will be an expanded emphasis on understanding the drivers of and remedies for socioeconomic disparities in aging. CEDA’s mission will be advanced via 5 cores: administrative and research support, program development (pilots), communication and dissemination, external networks, and external research resources support. The efforts proposed here are designed to lead to fundamental field-shaping research, innovative external grant applications to NIA and other agencies, valuable publicly available research tools and data sets, and translational research disseminated to inform aging-related policy.

Public health relevance
PROJECT NARRATIVE – Overall The proposed aging center will study population-level changes leading to an aging society – low fertility and longer life expectancy – as well as the effects of behavioral, community, and economic changes as they aggregate up to the societal level. CEDA will provide the infrastructure and support for fostering innovative research, conferences and other collaborations, and dissemination of data for analysis by researchers, policy- makers and others. Ultimately, the focus and structure will advance the development of theories and empirical data to address complex interrelationships underlying healthy aging and therefore lead to better policies for improved public health.